Investigating Cellular Communication in the Tumor Microenvironment in Pancreatic Cancer

PROJECT SUMMARY/ABSTRACT
Pancreatic ductal adenocarcinoma (PDAC) is projected to become the 2nd leading cause of cancer-related
deaths world-wide by 2030, largely due a lack of effective treatments. A major barrier to successful therapy is
the abundant fibrotic reaction in PDAC, which includes cancer-associated fibroblasts (CAFs). While many
pancreatic tumors are hypovascularized, endothelial cells regulate immune maturation and infiltration, tumor cell
metabolism, and metastatic dissemination. In PDAC, SLIT-ROBO signaling was recently identified as frequently
mutated. There have been contradictory genetic and pharmacologic studies in mouse models, indicating the role
of SLIT-ROBO signaling in PDAC is highly complex and context dependent. Our preliminary data indicate that
SLIT2 inhibits angiogenesis in human endothelial cells in vitro. Previous work showed that epithelial Slit2 deletion
promotes neural invasion and metastasis in PDAC. However, we find the majority of Slit2 is produced by
fibroblasts, while Robo receptors are expressed in endothelial cells. This proposal aims to uncover two key
aspects of SLIT-ROBO signaling in PDAC: a) fibroblast secreted SLIT2 (Aim1) and SLIT3 (Aim2) -dependent
impacts on the PDAC TME. In Aim 3 of this proposal, I will determine the fibroblast-specific contribution of dual
SLIT2 and SLIT3 deletion in primary human CAFs to angiogenesis and tumor cell growth using a novel
multicellular co-culture approach. Overall, the proposed experiments will provide a new understanding of
the SLIT-ROBO dependent cellular cross talk within the pancreatic TME.

Public health relevance
PROJECT NARRATIVE Pancreatic cancer (PDAC) is a deadly malignancy characterized by extensive fibrosis and immune suppression. The complex interplay between tumor cells and their surrounding stroma has not been fully elucidated. Since current therapeutic approaches targeting individual components of the tumor microenvironment have failed to benefit patients, the goals of the project are to: define 1) Slit2- and 2) Slit3- dependent tumor/fibroblast/immune cross talk using genetic mouse model approaches, and 3) elucidate the impact of dual SLIT2/3 deletion in primary human CAFs in vitro on angiogenesis and tumor cell growth.